Expanding the chemical probe development paradigm toward underexplored targets

SUMMARY/ABSTRACT
Despite advances in high-throughput screening technologies, initial hits require extensive optimization by
medicinal chemistry to yield molecules with the potency and selectivity needed for biological applications,
creating a significant bottleneck in small molecule drug discovery and chemical probe development efforts. In
this R35 MIRA proposal, I outline my research program consisting of two complementary research directions
aimed at expanding the scope of methodologies for chemical probe development toward underexplored
biological targets and, ultimately, accelerating drug discovery. Research A is focused on improving the
throughput of medicinal chemistry by expanding our first-of-its-kind high-throughput medicinal chemistry (HTMC)
platform, which is based on Sulfur(VI) Fluoride Exchange (SuFEx) click-chemistry reactions. Although I
previously demonstrated successful application of my HTMC platform to several well-characterized model
proteins, additional work is needed to enable targeting of underexplored proteins, including those that lack
distinct binding sites. In this research, we will address the challenge of developing chemical probes against
underexplored proteins by coupling our platform with a covalent ligand approach, both at the target protein level
(A1) and in a proteome-wide manner (A2). Successful completion of this work will expand the biological targets
accessible to our HTMC workflow, thereby accelerating probe development against underexplored proteins and
enabling elucidation of their biological functions and roles in human health and disease. In Research B, we will
develop strategies for synthesis and evaluation of subcellular location selective–probes. Modulation of small
molecule subcellular distribution, introduced by Christian de Duve in the 1970s, remains a promising yet
underexplored strategy in chemical biology and medicinal chemistry, largely due to the technical challenge of
developing subcellular-selective chemical probes. Our long-term goal is to establish a comprehensive medicinal
chemistry workflow to develop subcellular-selective probes and drugs. In this grant period, we will develop a
SuFEx-enabled method for extracellular-selective chemical probe synthesis (B1), demonstrate approaches to
assess organelle-selective target engagement (B2), and explore the potential of modulating organelle selectivity
as a medicinal chemistry strategy to improve cellular potency (B3). Development of chemical probes with
subcellular resolution will overcome a longstanding hurdle in medicinal chemistry and provide crucial insights
into spatio-specific protein functions in disease mechanisms. In total, the workflows and approaches that result
from the proposed research program will accelerate and expand the scope of chemical probe development in a
proteome-wide and spatio-defined manner, fundamentally advancing the fields of chemical biology and medicinal
chemistry. Application of the developed technologies and chemical probes will enhance our understanding of
living systems and provide proof-of-concept for novel therapeutic mechanisms of action to support drug
development efforts.

Public health relevance
NARRATIVE Although high-throughput screening yields a number of small-molecule modulators of biomedically relevant proteins, these ‘hits’ typically require substantial optimization to improve their biological functions via costly medicinal chemistry approaches, creating a significant hurdle to development of efficacious chemical probes and drugs. The proposed research program aims to address this limitation through two complementary research directions focused on developing generally applicable medicinal chemistry workflows for underexplored biological targets. Ultimately, application of these approaches and the resulting probes will advance our fundamental understanding of living systems and provide proof-of-concept for novel therapeutic mechanisms of action, thereby enhancing human health.